Data and Technical Development Core

Project Summary
CREATE’s newly structured Data and Technical Development Core (DTDC), formerly Data Core, includes bio-
statistical, data management, programming, and software development (including expertise in artificial
intelligence, machine learning, & Virtual Reality), and cybersecurity expertise. The DTDC will have access to
the resources at the Cornell Tech Campus and the Design & Environmental Analysis Center at Cornell Ithaca
and will also be supported by technical resources at Florida State University (FSU) and the University of Illinois
at Urbana-Champaign (UIUC). The DTDC will continue to provide an infrastructure for the coordination,
collection, management, and sharing of data; and provide critical statistical support including assistance with
sampling, analysis, and design and recruitment strategies for all research projects (including the Pilot Research
projects). The Core has detailed cybersecurity protection protocols that involve hardware, software, and
participant training solutions. Cybersecurity protection protocols will be applied to all data, projects, and study
participants and users will be queried about annoyance. The DTDC will also ensure that research activities are
conducted in compliance with regulatory agencies with regard to privacy and confidentiality. The DTDC will
collaborate with the Administrative Core (AC) in the development of data collection, entry, and training protocols
for all research personnel. The Core will also be responsible for providing the investigators with technology
support for the research projects. This will include the development of technology interfaces (e.g., VR), the
development of novel intelligent adaptive systems using machine learning, digital assistants, and other types of
technology tools. The Core will continue to use a variety of methods for data collection, including computer-
assisted instruments and computer-aided telephone interviewing software (CATI). During CREATE V, these
protocols will be expanded and adaptive data collection tools on mobile devices for study participants will be
included. Server-side applications for data collection (e.g., REDCap) will be implemented for survey data
collection. The DTDC will also develop data documentation manuals and data libraries for the projects and
assume responsibility for data scoring and integration. The Core will be responsible for: processing all data to
ensure its accuracy, consistency, and integrity; continuing to serve as a central repository for all Center related
data and documents; providing a framework to facilitate collaboration between Center personnel; and
implementing our detailed resource sharing plan (see Resource Sharing Plan). It will also continue to maintain
the SharePoint Server for the Center to share libraries of data, documents, presentations, etc. The DTDC will
continue to work with the AC in the preparation of project reports such as the progress reports for the NIH and
the External Scientific Board and Industry Advisory Council, and reports for the DSMB. In addition, the DTDC
will work with the Dissemination Core (DC) to assist with the preparation of publications and presentations.